Development of Diagnostic Antibodies for Acute and Chronic Chagas Disease

Project Summary/Abstract
Chagas disease, caused by infection with the parasite Trypanosoma cruzi, has been deemed the most
neglected of neglected tropical diseases. The parasite is transmitted to humans by bloodsucking insects
that usually live in cracks in the walls of mud and straw houses common to poor rural and urban
communities. It can also be transmitted through blood transfusion and mother-to-child transmission,
which is increasingly common. An estimated 10 million people are infected and 30-40% of those will
develop severe and often fatal heart disease due to the infection. High rates of immigration from Latin
America have brought many people who are unknowingly infected into the US, where doctors are
unfamiliar with the disease. Most people are infected as children, a time when infection is “brilliantly
treatable”, but only an estimated 1% of patients are treated. This is due, in large part, to the lack of an
effective means to diagnose infection. Infection can only be diagnosed by blood sampling but the quality
of rapid diagnostic tests currently available is poor. Multiple public health organizations have identified
the development of high-quality point-of-care rapid diagnostic tests for Chagas as an urgent need. Here,
we propose to generate a panel of antibodies that can detect T. cruzi, markers that circulate in the blood
during infection. We have identified 3 candidate diagnostic T. cruzi Ags that are present in blood and
highly conserved among all T. cruzi strains. Here, we will generate antibodies specific for these targets,
determine their binding characteristics, and test their ability to detect these markers in blood serum
obtained from dogs, non-human primates, and humans that acquired T. cruzi through natural infections.
Antibodies that display good diagnostic accuracy in these studies will be selected for further
characterization and development in future studies, so that they can be deployed in new high-sensitivity
point-of-care diagnostic tests for Chagas Disease. We have previously used these procedures to
develop a point-of-care diagnostic assay for Ebola virus that displays a sensitivity better than the current
gold standard, PCR. The successful completion of these studies will result in the first antibodies
diagnostic for T. cruzi infection, allowing construction of the first point-of-care assay that can detect
markers of Chagas Disease in the blood. This work will thus markedly improve our ability to diagnose
Chagas Disease, allowing early treatment and improved management of those who are infected.

Public health relevance
Project Narrative Currently, Chagas Disease, caused by infection with the parasite Trypanosoma cruzi, cannot be readily diagnosed in either the acute or chronic stages and the development of high-quality point-of-care rapid diagnostic tests for this disease are urgently needed. The proposed studies will result in a panel of high sensitivity diagnostic antibodies that can detect T. cruzi infection, which can then be deployed in point-of-care diagnostic tests. This will address a critical global health need by allowing the accurate diagnosis of Chagas Disease in multiple settings, which will markedly facilitate disease treatment and the improved management of disease complications.